LAUE PHOTOGRAPH OF AEROMONUS PROTEOLYTICA AMINOPEPTIDASE (AAP)

Using BioCARS Station 14-ID-B, the goal is to take a Laue photograph of this protein. One of the future goals of this project is to capture a substrate intermediate. Our first interest is to see if we can get an interpretable Laue diffraction image.